SLEEP RESTRICTION THERAPY IN MIDDLE -AGED AND ELDERLY INSOMNIACS

The purpose of this study is to assess the changes that occur over the course of modified sleep restriction therapy in middle-aged and elderly chronic incomniacs in whom there is no medial problem associated with the sleep disturbance.